Genomic Intensive Data Science Research, Education and Mentorship

Abstract
The Genomic Intensive Data Science Research, Education and Mentorship (GIDS-REM) program at the
University of Rochester aims to increase the number of researchers with strong quantitative skills in the
genomics workforce. The focus is on recruiting and retaining members of groups traditionally underrepresented
in biomedical fields. The proposal aims to 1) create a new track in genomics data science in the Goergen
Institute for Data Science Master’s program (GIDS-MS) and recruit a diverse group of scholars into the track;
2) build core competencies in genomics data science through curricular training, workshops, and research
experiences; and 3) retain GIDS-REM fellows in the genomics workforce through mentoring and cohort
building.
The innovative features of this proposal combine with existing strengths in research, academics, and
efforts to ensure diversity, equity, and inclusion at the University of Rochester. This proposal leverages
the framework and resources for the existing GIDS-MS program and implements a new curriculum that trains
students in theoretical and applied aspects of both data science and genomics. Through a partnership with the
David T. Kearns Center for Leadership and Diversity, the targeted recruitment strategies will bring in diverse
scholars from underrepresented groups as GIDS-REM fellows. The proposal implements a team mentoring
approach that will connect fellows to genomics research advisors throughout the University of Rochester and
its Medical Center and industry. This proposal applies the University of Rochester’s strengths in cancer
genomics at the Wilmot Cancer Institute and translational genomic research at the Clinical and Translational
Science Institute. Key aspects of the proposal are in its culturally responsive mentor training and strong
community-building to create inclusive spaces that allow GIDS-REM fellows to thrive. These
approaches will improve the retention of fellows in doctoral programs or in industry positions in the field of
genomics. The effectiveness of the program will be assessed using quantitative and qualitative
benchmarks, and instruments to evaluate mentor competency and student self-efficacy. The GIDS-REM
program will not only have a direct impact on the fellows and their career directions, but will have a broad
impact on the genomics community at the University of Rochester and beyond.

Public health relevance
Project Narrative The Genomic Intensive Data Science Research, Education and Mentorship (GIDS-REM) program at the University of Rochester creates a fellowship to train, mentor, and develop research experience in Genomics in data science master’s students from underrepresented groups. This program will increase the number of researchers with strong quantitative skills in the genomics workforce, diversify and strengthen the larger genomics community.